Timing and regulation of meiotic commitment

Project Summary/Abstract:
During meiosis, a diploid cell undergoes one round of replication followed by two rounds of
chromosome segregation to ultimately produce haploid gametes. A failure to properly segregate chromosomes
in meiosis can result in infertility, miscarriage, and trisomy conditions, such as Down syndrome. Despite the
importance of meiosis, there is a lack of molecular understanding of how cell-cycle regulatory networks
function to ensure that chromosomes properly attach to spindle microtubules in meiosis I and meiosis II. The
objective of this proposal is to determine the mechanisms of meiotic regulation that ensure proper chromosome
segregation in meiosis. These studies employ S. cerevisiae as the model organism due to the ease in
developing tools to address mechanistic questions. These innovative tools will allow the investigation of how
cells correct improper microtubule-kinetochore attachments, how cells set the duration of meiosis, and how
crossover position along homologous chromosomes affect microtubule-kinetochore attachments. The rationale
for the proposed research is that the questions were chosen to focus on processes that are likely to be highly
conserved, allowing the findings in budding yeast to uncover general mechanisms of meiotic regulation. Strong
preliminary data guided the following three specific aims: 1) Investigate how spindle checkpoint proteins
crosstalk with kinases and phosphatases at the kinetochore to regulate the timing and fidelity of chromosome
segregation in meiosis; 2) Determine how the spindle checkpoint is prematurely silenced during meiosis when
chromosomes are not correctly attached to spindle microtubules; and, 3) Determine how crossover location
along a chromosome can affect the fidelity of kinetochore-microtubule attachments. In the first aim, cell-cycle
regulators at the kinetochore will be tested for their role in maintaining the timing and accuracy of meiosis. The
second aim tests the novel hypothesis of a meiosis-specific mechanism for silencing the spindle checkpoint to
ensure the formation of gametes, even without proper chromosome segregation. The third aim addresses the
long unanswered question of why chromosomes with crossovers at sub-optimal positions are more likely to
mis-segregate. Strains will be developed that have chromosomes engineered to form a crossover at a specific
site and fast live cell imaging will monitor the attachment to microtubules. The innovative approach of
combining the latest imaging technologies to monitor kinetochore-microtubule attachments in engineered
strains allows the testing of novel hypotheses about cell-cycle regulation. The proposed research is significant
because the results are expected to reveal general principles of meiotic regulation important for protecting
genome integrity. Ultimately, the results will further our understanding of how errors in meiosis facilitate
developmental abnormalities.

Public health relevance
Project Narrative The proposed experiments will provide insight into the regulation of meiosis, a cell division pathway essential for the production of gametes, such as eggs or sperm. Errors in meiosis can cause a gain or loss of genetic material, which can lead to miscarriage, infertility, and trisomy conditions such as Down syndrome, the leading genetic cause of developmental disability. The experiments in this proposal address the fundamental question of how errors in meiosis occur so that we can learn how to prevent them.